Clinical Protocol and Data Management

The Vanderbilt-Ingram Cancer Center (VICC) Clinical and Protocol Data Management team (CPDM), known internally as the VICC Clinical Trials Office (CTO), provides investigators conducting translational and clinical investigators with the infrastructure necessary to conduct scientifically meritorious research on a local and national level. CPDM services are available to all Vanderbilt investigators conducting cancer-relevant trials. The CTO is operationally organized by Disease Team (DT) and provides regulatory and data management services, research nursing support, as well as contract and budget negotiation, quality assurance, data and safety monitoring and multi-center investigator-initiated trial (IIT) development programs. VICC places the highest priority on the safety of patients participating in research trials and continually strives to foster and maintain the highest level of oversight and compliance across the clinical and research enterprise. As a result of this long-standing commitment to research excellence, every interventional trial conducted at VICC must include a plan for data and safety monitoring. The NCI-approved VICC Data and Safety Monitoring Plan (DSMP), was revised and approved by the NCI in 2019. The plan outlines that while each PI is responsible for day to day oversight of their protocol, the initial scientific review conducted by the VICC SRC includes the assignment of a more detailed, protocol-specific plan for DSMC oversight based on the DSMP. Per the plan, the DSMC is independent of the SRC and has the right to modify the SRC recommendations within the parameters of the DSMP. Since the last reporting period, the CTO has made continuous process improvements and expansions within several service lines to adapt to the increasing complexity of cancer trials while developing new workflows to capitalize on opportunities provided by the Epic transition. The results of these changes are anticipated to reduce trial opening times and improve ability of investigators to meet accrual goals moving forward. During the project period, the total number of protocols managed by the CTO has increased by 27%. Among the trials conducted at VICC in CY18, 118 of the 452 (26%) protocols open to accrual were initiated or significantly influenced by VICC investigators, even when sponsored by industry partners. Importantly, VICC investigators have enrolled 492 patients to National Group studies during the project period. The CTO will continue to respond to and support the needs of its investigators by adapting its processes and workflows as the landscape of research advances, and remains committed to cancer prevention and improving outcomes for cancer patients.

Public health relevance
The application of basic and translational cancer research to clinical and population health advances is accelerating at an exponential pace, resulting in an increasingly complex interventional trials process. A reason for this complexity includes a rise in the bi-directional bench-to-bedside and -population integration into trials leading to an increase in complex specimen collection and processing. Additionally, as our understanding of cancer molecular biology grows, the need to subtype patients prior to enrollment based on biomarkers is leading to smaller subsets of patients, disease agnostic studies and trials with multiple treatment cohorts. This point is further compounded by the fact that new modalities of therapy, such as molecularly targeted agents and immune therapies with non-overlapping toxicities, have led to more complex treatment regimens. As Vanderbilt-Ingram Cancer Center (VICC) increases its centralization of Clinical Protocol and Data Management through the Clinical Trials Office (CTO), the breadth of trial portfolios is also increasing with focus from population sciences to detection, prevention, treatment and supportive care, covering the entire span of the cancer control continuum from cancer risk to end-of-life. All of these changes combine to place a heavy emphasis on the need to have a complex yet nimble CTO structure that allows rapid adjustments to accommodate new trial designs and new modalities such as cellular therapy, as well as to work with trans-institutional consortia in order to sustain an adequate and competitive portfolio of rapidly accruing trials. The primary mission of the CTO is to provide all investigators who conduct cancer-relevant interventional trials at Vanderbilt with every opportunity to implement and accrue patients to scientifically rigorous and meritorious research trials. The CTO provides efficient and technically sound services that allow VICC investigators to efficiently open and conduct studies, maintain the data integrity needed to share and publish results, and enhance the standard of care for cancer patients. Specific Aims of the CTO are as follows: Aim 1: To provide an organizational structure with facile operations through which all VICC investigators can conduct cancer-relevant interventional trials. CTO services are available to all Vanderbilt investigators conducting cancer-relevant protocols across the continuum of the cancer process . Aim 2: To offer tools enabling VICC investigators and CTO staff to conduct effective and accurate interventional trials. The CTO upholds the standards set by the International Conference on Harmonization’s Good Clinical Practice Guidelines (GCPs). The CTO facilitates faculty and staff training on GCP. The CTO provides research personnel to help investigators safely conduct all aspects of interventional trials, collect all specimens and data and to be able to report trial results in both the appropriate NIH systems, such as Clinical Trials.gov, and in the literature. Aim 3: To ensure the safety of our patients participating in clinical interventional trials. The CTO provides the tools necessary to enroll, monitor and report on patients enrolled on interventional trials at VICC. The CTO also supports a Data Safety Monitoring Committee that follows the NCI-approved VICC Data Safety Monitoring Plan.